Preclinical evaluation of an otoprotectant TT002

Project Summary
Ting Therapeutics LLC is a pharmaceutical company developing drugs to prevent and treat hearing loss.
Cisplatin is one of the most widely used drugs to treat cancers. However, cisplatin therapy causes hearing loss
in 40-60% of the patients. To date, no drugs have been approved by the Food and Drug Administration for
protection from cisplatin-induced hearing loss (CIHL). Most candidate compounds currently in pre-clinical and
clinical trials are related to antioxidants, vitamins, and glutathione metabolism, many of which, such as sodium
thiosulfate, interfere with cisplatin’s ability to kill the tumor cells. We have performed unbiased in silico virtual
screens for otoprotectants against CIHL and identified 20 FDA-approved drugs including TT002, known as
niclosamide, an anthelmintic (gut worm) drug used in humans world-wide for nearly four decades. In vitro: TT002
showed a comparable level of protection against cisplatin damage in a cochlear cell line to kenpaullone, with an
IC50 of 0.17 μM, substantially (>10X) lower and better than four other benchmark otoprotectants. Moreover,
TT002 did not interfere with cisplatin anti-cancer activity in vitro. In vivo: TT002 attenuates hearing loss in adult
mice treated with cisplatin (30 mg/kg once) when delivered intraperitoneally (IP) at 10 mg/kg/day for 4
consecutive days. Interestingly, TT002 also protects against NIHL (100 dB SPL 8-16 kHz for 2 hrs) in adult FVB
mice when delivered IP at 10 mg/kg/day for 4 consecutive days. In this SBIR Phase II, we will perform
Investigational New Drug-enabling experiments to test TT002’s effect on cisplatin’s tumor killing efficacy in vivo
and to conduct efficacy studies to define an optimal dosing regimen and therapeutic index. The long-term goal
is for TT002 to become a standard otoprotective drug of cisplatin-based therapies. For this purpose, we will
demonstrate TT002’s efficacy in a mouse model of cisplatin ototoxicity that mimics the administration protocol in
cancer patients (Aim 1). We will determine pharmacokinetics and pharmacodynamics profiles in blood and
perilymph, as well as efficacy, in a guinea pig model for cisplatin-induced hearing loss (Aim 2). This Aim will be
performed under contract with an independent and reputable Contract Research Organization, Turner Scientific
LLC. Finally, we will test drug-drug interactions in vitro and we will verify, in vivo, that TT002 does not interfere
with cisplatin’s anti-cancer activity in mouse model xenografts (Aim 3). By successfully completing these studies,
Ting Therapeutics will obtain critical data necessary for the initiation of Investigational New Drug enabling
complaint preclinical studies and subsequent clinical trials. Ting Therapeutics has filed a Patent Cooperation
Treaty (PCT) for both the US and international rights. The completion of this proposal will allow Ting Therapeutics
to initiate conversations with pharmaceutical companies and venture investments for the commercialization of
TT002.

Public health relevance
PROJECT NARRATIVE The work in this proposal focuses on further preclinical development of TT002 to protect from cisplatin-induced hearing loss. If successful, this proposal will allow Ting Therapeutics to initiate conversations with pharmaceutical companies for the manufacturing and commercialization of TT002 and for IND-approval by the FDA for its use as a standard otoprotective component of cisplatin-based therapies.